Analysis of the Performance of Putative Plant Barcodes

I was one of two presenters (along only with Damon Little of the New York Botanical Garden) to a subset of the Plant Working Group invited to the Edinburgh Conference "Selecting Barcode Loci for Plants" specifically to analyze standardized data, to select a plant barcode. The other conference participants sequenced seven candidate barcode loci across a broad range of land plants. Damon and I analyzed the resulting data, so the conference participants could select loci to constitute a plant barcode. The Edinburgh Conference selected rbcL and matK as the two plant barcode loci.